Improving Adherence to Breast Cancer Treatment Guidelines in Nigeria

PROJECT SUMMARY/ABSTRACT
Background: Breast cancer is the most common cause of cancer incidence and mortality in women in Nigeria.
Survival is poor, in part due to inadequate access to effective treatment. The National Comprehensive Cancer
Network (NCCN) Harmonized Guidelines for sub-Saharan Africa (SSA) were developed to promote delivery of
evidence-based, context-appropriate breast cancer care. Dr. Romanoff’s prior work shows that receiving multi-
disciplinary, guideline-concordant breast cancer care in Nigeria is associated with improved outcomes.
Nonetheless, guideline implementation and adherence are sporadic and have not been systematically evaluated.
The overall goal of this K08 proposal is to facilitate Dr. Romanoff’s development into an independent investigator
in global oncology, focusing on strategies to enhance evidence-based breast cancer care delivery in resource-
limited settings. This research aims to develop and evaluate strategies to improve healthcare provider adherence
to clinical practice guidelines for breast cancer care in Nigeria. Candidate: Dr. Romanoff is a Breast Surgical
Oncologist at the Icahn School of Medicine at Mount Sinai, where she is an Assistant Professor in the Department
of Global Health and Health System Design, as well as a Global Cancer Disparities Researcher at Memorial
Sloan Kettering Cancer Center (MSK). Aims for candidate development include education and training in: 1)
fundamentals of health services research, 2) implementation science, and 3) global breast oncology. With the
candidate development and research activities proposed, Dr. Romanoff will develop the tools necessary to
become an independent investigator and leader in the field of global oncology, and meet her ultimate goal of
improving breast cancer outcomes in resource-limited settings worldwide. Research: This research will use
rigorous implementation science frameworks and methodologies to accelerate adherence to the NCCN
Harmonized Guidelines for SSA in Nigeria, with the ultimate goal of reducing the evidence-to-practice gap and
improving evidence-based breast cancer treatment. To achieve this, Dr. Romanoff will leverage the research
infrastructure of the African Research Group for Oncology (ARGO), a research consortium including MSK and
26 Nigerian academic institutions. The overall hypothesis is that implementation of structured, multi-level
strategies to enhance adherence to breast cancer care guidelines in Nigeria will be acceptable, appropriate,
feasible and adoptable – and show promise to change clinical practice. Study aims are to: 1) identify multi-level
barriers to guideline-concordant breast cancer care in Nigeria, 2) develop evidence-based implementation
strategies to improve adherence to breast cancer clinical practice guidelines in Nigeria, and 3) rigorously
evaluate selected implementation strategies in a pilot study in Nigeria. The rationale that underlies this proposal
is that implementation of context-appropriate strategies to promote guideline adherence will improve breast
cancer care delivery in Nigeria, and ultimately patient survival.

Public health relevance
PROJECT NARRATIVE This research will assess barriers to guideline-concordant breast cancer care in Nigeria, and methodically develop and evaluate implementation strategies to promote guideline adoption. The proposed research is relevant to public health because it aims to improve the evidence-based treatment of breast cancer, the leading cause of cancer-related death for women in Nigeria. The results of this work will generate fundamental knowledge and strategies to inform healthcare leaders and policymakers about effective methods to facilitate adoption of evidence-based cancer care in resource-limited settings, thereby promoting treatment that improves survival.